A multitargeted nanocarrier inhibitor of undruggable transcription factors for treating castration resistant prostate cancer

Project Summary
This project addresses the critical need for treatments of castration resistant prostate cancer
(CRPC) by proposing to engineer and develop a novel, nanostructured pharmaceutical
(P-TRIS5) which will target tumor cells and deliver two potent, synergistic therapeutics (an
siRNA and a small molecule) to inhibit the androgen receptor and RUNX, two commonly
implicated transcription factors in CRPC.
We will study the new compound using in vitro and in vivo models that are well-established for
CRPC and seek to show 1) effective in vitro targeting and cellular uptake, and 2) effective
delivery and efficacy in two xenograft mouse models. Parabon NanoLabs has significant
experience in the development and validation of rationally designed, nanostructured
pharmaceuticals and will leverage existing infrastructure, expertise, and collaborations to
investigate the potential for the proposed CRPC targeted drug.
Our synthesis methodology begins with the design of P-TRIS5 using Parabon’s Essemblix™ Drug
Development Platform, a powerful combination of computer-aided design (CAD) software for
designing self-assembling DNA nanocarriers and proprietary nanofabrication methods for their
production. Next, the two therapeutics and a targeting peptide will be conjugated to the
nanocarrier using commercially available compounds and purified by standard protocols.
We will measure the performance of P-TRIS5 by monitoring a fluorescent label on the
compound for targeting (via fluorescent confocal microscopy in vitro) and tumor growth via
bioluminescent full-body live imaging. Off-target cytotoxicity will also be measured in vivo to
demonstrate selective targeting of the tumor. Post-mortem excised tissues will be analyzed to
determine the extent of inhibition of downstream targets in the animal model.
The success of this project will create new avenues to rationally design nanostructured
pharmaceuticals against many kinds of cancer. Our focus on CRPC, a prostate cancer with a
critical need for new therapies, is driven by an abundance of knowledge about the molecular
biology involved and the synergy formed by a combination of small molecules and siRNA to
target drivers of the most dangerous variants of this deadly disease.

Public health relevance
Project Narrative This NIH STTR Phase I project will create a novel therapeutic for the treatment of castration resistant prostate cancer (CRPC). The proposed therapeutic will incorporate targeting molecules specific to prostate cancer that will enable it to bind and be taken up by prostate cancer cells. The therapeutic will carry a dual payload to inhibit the activity of key CRPC transcription factors, a class of proteins previously considered to be “undruggable.”